Impact of Pregnancy Dental Benefits on Dental Care Utilization among Pregnant Women and Young Children

Poor oral health during pregnancy may have long term implications for the oral and overall health of expectant mothers and their children. For example, children of mothers with high levels of tooth decay have three times the odds of developing caries before their sixth birthday. Tooth decay is the most common chronic disease of childhood and particularly acute for non-Hispanic Black and Hispanic children who experience more than twice the rate of untreated decay compared with non-Hispanic white children. While pregnancy increases susceptibility to oral health problems, pregnant women are less likely to visit the dentist (44%) than reproductive-aged women who are not pregnant (65%). The objective of this application is to use quasi-experimental methods to estimate the effects of Medicaid pregnancy dental benefits on dental care use among pregnant women and subsequent outcomes among their children. Our central hypothesis is that pregnancy dental benefits will increase the use of all service types among pregnant women and increase preventive care but reduce the need for restorative treatment among young children by delaying or preventing the onset of dental caries. The central hypothesis will be tested by pursuing three specific aims: 1) to examine the effects of Medicaid pregnancy dental benefits on reported dental visits and claims-based measures of the use of preventive and restorative dental services among pregnant women; 2) to examine the effects of Medicaid pregnancy dental benefits on later dental care use among children ages 2-11 who were exposed to the policy while in utero, including reported dental visits, claims-based measures of the use of preventive and restorative dental services, out-of-pocket spending on dental care, and unmet needs for dental care due to cost; and 3) to evaluate the effects of Medicaid pregnancy dental benefits by race and ethnicity and by county-level measures of access barriers and facilitators including dentist supply, federally-qualified community health center supply and investment, and area-level social determinants of health (e.g., area deprivation index). The research proposed in this application is innovative because it will be among the first to examine how children’s exposure to Medicaid dental benefits while in utero affects their later dental care utilization, it will link mothers and their children in a subset of our analyses, and we will apply newly developed methods to address variation in the timing of state policy changes. The proposed research is significant because pregnant women and children underutilize recommended dental services, untreated dental caries among children may interfere with their development, and there are persistent disparities in dental visit rates and oral health by race and ethnicity. The public health impact of this research will be to provide critical new evidence on whether pregnancy dental benefits have long-lasting impacts on children who were exposed to the policies while in utero and to assist policymakers in assessing the full scope of the benefits and costs of these policies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will produce rigorous evidence on the impacts of pregnancy dental coverage policies that may inform state decisions to newly adopt or maintain coverage. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to enhancing health and reducing illness. This application is also relevant to the part of NIDCR’s mission that pertains to improving dental, oral, and craniofacial health, and to the part of NIMHD’s mission that pertains to improving minority health and reducing health disparities.